Mechanisms of Physiological Organ Shrinkage

PROJECT SUMMARY
Many adult organs--for instance, intestine, mammary gland, skeletal muscle, skin—respond to reduced
levels of functional demand by shrinking their physical size. In these organs, cells are lost faster than they are
made, leading to a reduction in total cell number. The intestine is a broadly conserved exemplar of demand-
driven organ shrinkage. In wild animals, cyclic periods of starvation cause intestinal size to shrink by 60-75%.
Humans also undergo healthy intestinal shrinkage, but excessive or dysregulated cell loss can quickly become
pathological, as seen in enteropathies like celiac sprue, endotoxemia, and giardiasis. Yet—unlike the
mechanisms that balance cell division/loss during everyday turnover—the mechanisms that tune cell
imbalance for physiological shrinkage are virtually unknown.
The roadblock to mechanistic investigation of intestinal shrinkage has been the lack of a tractable
laboratory model, which must allow cells (and their dynamic behaviors) to be monitored across time and must
possess cell-specific markers and other tools to facilitate mechanistic studies. Historically, studies used
rodents, but modern research protocols cannot replicate natural famine/feast cycles.
My lab has developed a new invertebrate model of intestinal shrinkage that is both tractable and
genetically manipulable: the Drosophila adult midgut, akin to the vertebrate small intestine. We demonstrate
that intestinal shrinkage is conserved in Drosophila, and we document that its underlying basis is the massive
squeezing-out of now-superfluous enterocytes through active extrusion.
Here, we investigate intestinal shrinkage from both sides of the equation for net cellular balance: mature
cell loss (Aim 1) and stem cell capacity (Aim 2). Our studies leverage the midgut’s superlative toolkit of cell-
specific genetic reporters and our own pioneering innovations for real-time and longitudinal imaging of
functioning midguts inside live animals. In Aim 1, we ask how the gut senses loss of ingested food—
mechanical compression, lack of nutrients, or both. We test if two known regulators of extrusion, the
transcriptional co-activator YAP/Yorkie and intercellular Ca2+ waves, function during shrinking to increase
extrusions. Third, we probe whether a shrinking gut regulates cell extrusions at the organ scale or at the level
of individual cells. In Aim 2, we seek the mechanisms that cause a 75% culling of the stem cell pool during
shrinkage—even as stem cell mitoses paradoxically increase. We will test if stem cells initiate non-self-
renewing divisions, adopt terminal fates directly, and/or activate apoptosis.
The fly gut’s digestive physiology, stem cell lineages, and molecular regulation are similar to humans.
Hence by elucidating the cell-to-organ scale mechanisms that operate at this frontier of tissue biology, this
project may yield leads for therapies to treat cellular imbalances in human disease.

Public health relevance
PROJECT NARRATIVE Many adult organs, including the intestine, grow and shrink repeatedly across an animal’s lifetime to respond to its dynamic functional needs. During physiological shrinkage, live cells are purged out of the tissue (extrusion) and stem cells are culled, yet we know virtually nothing about the mechanisms that underlie these size- controlling behaviors. Here, we will leverage powerful live imaging and analysis methods developed by my lab to address fundamental questions about cell extrusion and stem cell behaviors during intestinal shrinkage; the knowledge we generate will create a conceptual framework that will inform vertebrate and possibly human studies of the intestine in both health and disease.